Regulation of hematopoietic stem cells under low oxygen tension

ABSTRACT
Hematopoietic stem cells (HSCs) generate all mature blood cells while reproducing themselves in a process,
namely self-renewal. Their presence in the bone marrow (BM), mobilized peripheral blood, and cord blood
(CB) has allowed their utility in the treatment of both malignant and non-malignant hematopoietic diseases via
transplantation. However, the rarity of HSCs and the difficulty of expanding them can be a limitation for their
applications. Thus, a better mechanistic understanding of HSC regeneration that might contribute to their
homing, engraftment, and self-renewal is vital to improving HSC-based therapies. In the bone marrow, HSCs
reside in a microenvironment where the oxygen tension is low (1~5%). Previous work showed that the low
oxygen tension (hypoxia) provides a metabolic niche to facilitate HSCs’ functionality in vivo or enhances HSC
expansion in vitro. Our recent work from mouse BM cells revealed a significant loss of phenotypical and
functional HSCs if harvested in ambient air (normoxia). In contrast, HSCs collected and processed under
hypoxia demonstrated higher engraftment and self-repopulating capacity. While these findings are interesting,
mechanisms behind this distinction are still poorly understood but have the potential to improve hematopoietic
cell transplantation (HCT) and gene therapy. The central goal of this proposal is to understand the signaling
and metabolic alterations in HSCs under hypoxic conditions and to explore the potential to manipulate these
processes in normoxic conditions to improve HSC functionality. We hypothesize that hypoxia alters the
expression of genes involved in regulating lysosomal function, mitochondrial integrity, and iron metabolism to
support self-renewal and prevent oxidative damage or differentiation. We have three major aims. In Aim 1, we
will determine how hypoxia activates TFE3, a master transcriptional factor for lysosomal biogenesis, to
facilitate self-renewal. We will specifically focus on the upstream regulatory elements, such as amino acid
availability, and the function of a few TFE3 targeted genes in this process. In Aim 2, we will determine the role
of Rho-associated kinase 1 (ROCK1) in regulating mitochondrial fission, a process that is suppressed by
hypoxia to prevent oxidative damage in HSCs. In Aim 3, we will explore the role of iron metabolism in driving
oxidative damage and differentiation of HSCs, and how a hypoxic environment prevents these processes. In
this aim, we are particularly interested in exploring iron chelator as a potential treatment to improve HCT.

Public health relevance
PROJECT NARRATIVE Hematopoietic stem cells (HSCs) reside in a microenvironment where the oxygen tension is low. In this proposal, we will explore how low oxygen tension (hypoxia) promotes HSCs’ function through gene expression and metabolic control. The outcome of this proposal will ultimately facilitate HSCs expansion and maintenance for therapeutic applications, such as bone marrow transplantation, in patients with blood diseases.